Administrative Core

ADMINISTRATIVE & RESEARCH SUPPORT CORE: PROJECT SUMMARY/ABSTRACT
The Administrative & Research Support Core (ARSC) will provide leadership and guidance to the Center on
Healthy Aging Behaviors and Longitudinal InvestigationS (CHABLIS) as it seeks to promote a sustained
research and infrastructure development program that leverages longitudinal data from observational and
interventional studies to examine how demographic and economic factors affect health-related behaviors
(HABs) and outcomes among older adults. ARSC PI and Center Co-PI David Meltzer will work closely with
fellow Co-PI Kathleen Cagney and the Executive Committee and External Advisory Board. These committees
will provide expertise in the demography and economics of aging, HABs, and longitudinal investigations, and
will represent diverse disciplines in the social and biological sciences, including economics, sociology, public
policy, internal medicine, and public health sciences. A Diversity Committee will also provide guidance to
CHABLIS in supporting research efforts of Center Associates and Affiliates from underrepresented
backgrounds. The main goals of the core include: 1) providing strategic vision, scientific leadership, and
administrative structure to the Center in order to foster active engagement of Center members, 2) providing
operational management for CHABLIS, including fiscal management and record keeping as well as tracking
outcomes for all cores for reporting requirements to the NIA and the Coordinating Center, 3) developing,
identifying, reviewing and monitoring pilot projects in a manner that is consistent with the overall goals of the
Center, and 4) providing a full suite of communication, research dissemination and support services to Center
members to increase research productivity and enhance career development among junior members.